NEUROGENOMICS CORE

PROJECT SUMMARY/ABSTRACT – NEUROGENOMICS CORE
Neurogenomics research, including analysis of DNA, RNA and the epigenome, consisting of investigation of
chromatin and methylation, is increasingly important in studies of intellectual and developmental disabilities
(IDDs). For example, neurogenomics analysis can identify the cause of human IDDs as well as determine the
mechanism by which genes are regulated in animal or cell-based models. The Neurogenomics (NGEN) Core
provides standard and innovative genomic assays that range from genotyping of DNA variants in human
subjects through single cell RNA-sequencing or evaluation of accessible chromatin in neural progenitor cells.
The NCEI with the NGEN Core will establish spatial transcriptomic technology, making it possible to investigate
gene expression in the context of tissue architecture. Further, the NGEN Core provides computational and
bioinformatic analysis of large datasets that emerge from next-generation sequencing (NGS) experiments and
will train students and postdoctoral fellows. The NGEN core is flexible to relinquish old services that are no
longer utilized or cost effective, to implement innovative services that will enhance IDD research and discovery.
The team consists of a Director and Associate Director with complementary expertise in human genetics,
functional genomics and epigenomics. The Operations Directors have hands-on roles in implementing and
establishing new technologies or bioinformatic services that are performed by senior technical staff. The
NGEN Core has an advisory committee needed to ensure optimal service and to help decide which services to
offer in the Core. The NGEN Core Components are part of established shared facilities at Einstein that also
has oversite from the Cancer Center and College. One of the challenges in performing genomics research is
how to choose among many different assays that are available. The NGEN Core provides guidance to IDDRC
investigators in a prioritized manner, from study design, to experimental optimization to bioinformatic analysis.
For this, the Directors meet with individual investigators to provide guidance in helping to choose assays that
are best suited for their particular research question. Members of the IDDRC will receive prioritized access to
NGEN Core services and personalized consultation. The IDDRC Pilot Award and Voucher program is also
available through the ADM Core on a competitive basis, making it possible for investigators to initiate
neurogenomics projects even if current grant funding is limited. Through this facilitated availability of a wide
range of services and innovative technologies involving critical aspects of genomic analysis, the NGEN core is
an essential component of the IDDRC.